ANIMAL IMAGING CORE

The purpose of the Animal Imaging Core (Core E) is to support the translational research objectives of the SPORE by (1) providing imaging support for studies of prostate tumor models, and (2) investigating preclinical models for developing, testing, and validating new treatments, both genetic and chemotherapy, to enhance treatment of prostate cancer. The Animal Imaging Core is responsible for the following: - Support state-of-the-art MR, PET, and optical imaging facilities for optimal small-animal imaging studies - Develop technical methods to optimize MR and PET studies - Provide magnetic resonance spectroscopy (MRS), optical and radionuclide imaging to support preclinical pilot studies in the Developmental Research Program (DRP) - Development and validation of imaging biomarkers

Public health relevance
As transgenic and knockout rodent models of have been developed that are increasingly more accurate in modeling human disease, the ability to track these tumor models longitudinally is essential. With laboratory access to such clinical modalities as MRI, PET, CT, SPECT, etc., the results of small-animal imaging are immediately relevant to the SPORE in Prostate Cancer and for translation to the clinic.